Quantification of microstructures in the entorhinal-hippocampus pathway as a sensitive biomarker for neurodegeneration during the preclinical stage of Alzheimer's disease

Project Summary/Abstract
Alzheimer's disease (AD) is a global issue that must be solved urgently because of its significant impact on public
health and economics, as well as the quality of life of individuals in the United States and other aging societies.
Once cognitive impairment occurs in the AD continuum, there are great difficulties in modifying the devastating
disease process. Pathological changes inside the brain begin silently many years before the onset of cognitive
impairment. This long “preclinical” stage provides us with an opportunity for timely therapeutic and preventive
interventions. Therefore, the development of tools that can predict future cognitive decline during the preclinical
stage of AD is crucial. There is a consensus that neurodegeneration has a stronger correlation with cognition in
the disease progression along the AD continuum, compared to the diagnostic AD biomarkers such as amyloid
and tau proteins. In contrast, neuroimaging modalities currently used to detect biomarkers for neurodegeneration
are not sensitive enough to detect minute changes during the preclinical stage of AD. Here, Dr. Yuto Uchida
hypothesized that myeloarchitectonic features observed in the entorhinal-hippocampus pathway could serve as
sensitive neurodegenerative biomarkers given that AD pathogenesis occurs in the entorhinal cortices. In this
project, he will conduct a proof-of-concept study to examine microstructural neurodegeneration of the entorhinal-
hippocampus pathway in a combined framework: ex vivo ultra-high-field quantitative MRI followed by histological
verification in Aim 1, and in vivo ultra-high-field quantitative MRI in clinical settings for healthy controls in Aim 2
and for preclinical and prodromal AD individuals in Aim 3. In Aim 1, postmortem hemibrains will be scanned on
a human 7T MRI scanner and compared with the corresponding histology in the entorhinal-hippocampus
pathway to fill the gap between the MRI findings and microscopic observations. In Aim 2 and Aim 3, cutting-edge,
deep learning-based susceptibility tensor imaging (DeepSTI) and DeepSTI-based tractography will be applied
to an ongoing cohort study (RF1AG071515), which comprises healthy, preclinical, and prodromal AD individuals.
In Aim 2, reference ranges for quantitative MRI measures in the entorhinal layer II and the perforant path fibers
will be established. In Aim 3, comparative analyses of these quantitative MRI measures among the groups will
be done cross-sectionally, which will be followed by a longitudinal study to examine these associations with
cognitive decline along the AD continuum. In summary, the long-term objective of this K99/R00 application is to
support Dr. Yuto Uchida’s ability to conduct studies aimed at developing biomarkers for neurodegeneration that
can visualize and quantify microstructural brain alterations during the preclinical stage of AD using ultra-high-
field quantitative MRI. Dr. Uchida will be co-mentored by Drs. Kenichi Oishi, Xu Li, Jeremias Sulam, Hanzhang
Lu, and Juan C. Troncoso, who are experts in neuroanatomy, MRI physics, deep learning-based algorithms,
neurofunction, and histopathology, respectively. Having multiple mentors with different areas of expertise can
broaden Dr. Uchida’s technical and scientific skills and further his goal of becoming an independent investigator.

Public health relevance
Project Narrative Once cognitive impairment occurs in an individual with Alzheimer’s disease, it is difficult to modify the devastating disease process. The long-term goal of this project is to develop a non-invasive tool that can visualize and quantify microstructural brain changes during the preclinical stage of Alzheimer’s disease. To this end, Dr. Yuto Uchida will conduct a proof-of-concept study to investigate the feasibility of ultra-high-field quantitative magnetic resonance imaging as a sensitive biomarker for neurodegeneration in preclinical Alzheimer’s disease.